Healthy Brain and Child Development National Consortium Data Coordinating Center

PROJECT SUMMARY
The landmark Healthy Brain and Child Development (HBCD) study will provide a representative reference data
resource to the scientific community enabling unprecedented investigation of neurodevelopment and the impact
of environmental, genetic, and biological factors on brain and behavioral health and developmental trajectories
from infancy through childhood. Through this study, the HBCD Consortium will recruit and retain a
sociodemographically diverse cohort of 7,500 pregnant women from 25 U01 sites (and five additional subcontract
sites for 30 total data collection sites) across the U.S. and follow these families and their children through the
first decade of life. Children will undergo rigorous data collection across modalities including neuroimaging,
neurophysiology, behavioral and cognitive assessments, and collection of biospecimens via a study protocol
developed by field-leading experts. The Healthy Brain and Child Development Data Coordinating Center (HDCC;
U24 DA055330) will provide the leadership, management, and oversight of data collection, quality control,
curation, processing, management, sharing, and analytics to facilitate and support the activities of the HBCD
Consortium and ensure its success. This administrative supplement is necessary to accommodate significant
costs unbudgeted in the original HDCC submission and required for the successful establishment of these
procedures. As detailed, these costs are directly related to multiple factors outside the purview of the original
proposal, including: 1) a larger number of U01 and subcontract sites than originally budgeted based upon the
final configuration of the HBCD Consortium; 2) greater costs for required computer hardware due to inflation-
and supply chain-related cost increases since the original submission in March 2021; 3) greater data storage
infrastructure requirements to accommodate collection of increased amounts of PII data based upon the final
Consortium-defined study protocol; 4) varying levels of experience and expertise with key study elements (e.g.,
performing MRI scans in infants and toddlers without the use of sedating medications) across HBCD Consortium
sites; and 5) varying extant resources for items determined by the Consortium to be critical for successful MRI
data collection (e.g., noise attenuating headphones) across HBCD Consortium sites. Critically, the requested
support is only for items required in Year 1 of the Consortium’s activities in order to satisfy study timelines and
facilitate the successful, coordinated launch of the multimodal protocol across all U01 and subcontract sites,
while concomitantly ensuring the fidelity of data collection and management procedures supported by the HDCC.
The result of this field leading investigation will be a state-of-the-art, longitudinal data set of unparalleled scale
which provides deep understanding of the biological and environmental factors that affect a child’s health, brain,
and behavioral development and shapes research, clinical care, and public policy for decades to come.

Public health relevance
PROJECT NARRATIVE The Healthy Brain and Child Development (HBCD) study will encompass data collection from a cohort of 7,500 mother-child dyads across 25 independent U01 sites and five additional subcontract sites over a range of modalities including harmonized neuroimaging, neurophysiology, behavioral and cognitive assessments, and the collection of biospecimens. This administrative supplement will enable the HBCD Data Coordinating Center to fully support the successful and coordinated launch of data collection activities across the Consortium during Year 1 of the study through the accommodation of required and unanticipated costs secondary to inflation- and supply chain-related price increases, larger numbers of data collection sites than originally budgeted, and varied levels of extant experience and expertise for specific critical study elements across U01 and subcontract sites.